SysBio FAIRplex: a FAIR PLatform for EXploration of Systems Biology

SysBio FAIRplex
Abstract
We propose building the SysBio FAIRplex, a FAIR PLatform for EXploration of Systems Biology, to
accelerate the transformation of biomedical data from many sources into insights from many
researchers into improved health for all.
Our team includes leadership from the teams that built, harmonized, and manage platforms for many
directly related projects, including AMP AD, AMP AIM, AMP CMD, AMP PD, AMP RA/SLE, AMP T2D, and
the Global Parkinson’s Genetics Program (GP2). We have extensive governance, security, scientific, and
technical experience with the realities and complexities of real-world execution, which we will use to
mitigate legal, technical, contractual, and cross-organizational dependency risks.
Our four Aims represent the four FAIR principles, which we will use to maximize the value of the AMP
data ecosystem by (a) expanding the number and diversity of researchers who can find and access the
data; (b) increasing the number and variety of tools that can be used to analyze the data; (c) enabling
“big-N” science by combining silos into larger virtual cohorts; and (d) connecting the AMP ecosystem to
the larger NIH and global data and research ecosystem.
The SysBio FAIRplex system has
three layers:
● Discovery via a single
portal for researchers to
find relevant data and
tools
● Exploration and
Analysis with a mix of
graphical and
computational tools,
including the ability to
transition from GUI to
code
● Data, combining
federated access to
original data with
Figure 1: The SysBio FAIRplex Portal provides a single point-of-entry for diverse
centralized access to
researchers, providing access to point-and-click exploration tools and to
harmonized data. cloud-based analysis workspaces.
We will take an iterative approach to implementation.
● We will start with early and broad activation of all workstreams in parallel, stakeholder
engagement, and requirements clarification.
● We will then proceed with building initial prototypes of all systems on a subset of the data,
including data harmonization, aggregate exploration, file search, and analysis workspaces. We
will use those prototypes to get stakeholder feedback and to iterate on the requirements.
● Once the initial prototypes are up and running, we will iteratively add more data, add more
tools, add more researchers, and gather more feedback.
We are excited about the vision of the SysBio platform, and look forward to FAIRplex making it real..
SysBio ROA (OTA-24-008) 3